Scientific Direction Adminstrative Unit (OPERATIONS CORE)

The Operations Core is responsible for integrating the Center's scientific and infrastructure aims. The Units within the Core each provide services to the Research Methods Core and to each of the projects outlined in the Principal Research Core, and are focused on ensuring that the day to day operational goals of the Center are fulfilled. Moreover, the Operations Core has been primarily responsible for the planning and execution of our transition from the previous ACISR structure to the new structure proposed in this application as described in the Overview.